Foundational Elements of an Alternate Scientific Approach to Developing Veteran-centric Precision Cognitive Restoration Interventions

The purpose of this SPiRE is to identify the supports and barriers to scalability of Veteran-tailored iTBS and
APT across neurologic conditions, with the longer-term goal of providing an empirical basis for the tailoring of a
broader range of cognitive rehabilitation strategies to optimize each Veteran’s cognitve function in daily life. After
Veterans receive standard cognitve rehabilitation, cognitive impairments often persist and if they do make gains
there is limited carry-over to daily function. The tenets of precision neurorehabilitation suggest that tailored
interventions will optimize gains and carry-over, but precision-tailoring of cognitive rehabilitation will only be
possible if researchers develop and test scalable approaches for identifying, organizing, and analyzing the
multitude of Veteran-specific variables driving and influencing treatment responsiveness. Aligned with this need,
this project addresses long-standing scientific barriers to understanding treatment responsiveness, particularly
study sample heterogeneity and individual variability. We address study sample heterogeneity by linking
Veterans, across TBI and ischemic stroke, according to levels of cognitve impairment. We create a cohort of
Veterans with a homogeneous level of cognitve impairment, thereby enabling explication of person-centric
factors influencing treatment responsiveness and carry-over to daily function. To further scale-up the science of
precision neurorehabilitation, we advance understanding of how to design within-subject cross-
over studies. Advancing understanding of the basic study design elements will be achieved by leveraging our
knowledge of intermittent Theta Burst Stimulation (iTBS) and iTBS paired with Attention Processing Training
exercises (iTBS + APT). iTBS is advantageous as it robustly improves working memory with just one treatment
session. These interventions, together, are advantageous as they can each be tailored to a Veteran’s unique
cognitve challenges and to target the neural site, unique to each Veteran’s neuropathology. These two
interventions also directly address cognitive deficits, while simultaneously inducing neuroplasticity in neural
regions hampered or impaired by neural injury. For this SPiRE project, we will study Veterans with moderately
impaired cognition who, after standard cognitve rehabilitation, continue to struggle with daily life requiring
assistance with complex instrumental activities of daily living (IADL). Veterans will participate in a series of two
within-subject treatment studies, conducted on two separate days, 2-weeks apart. Veterans will be randomly
assigned to first receive a single session of Active iTBS or Placebo iTBS and then they will receive APT paired
with their assigned iTBS (Active iTBS + APT vs Placebo iTBS + APT). We will test if diagnosis moderates the
effects of these interventions on both immediate and persisting change in cognition. For immediate effects,
we use a novel testing battery and for persisting gains we use established and feasible neuropsychological tests
as well as an established test of cognitive function during IADL. The SPiRE results will be used to obtain pilot
data and examine feasibility in terms of study attrition relative to Veteran fatigue, mood and Veteran reports of
suitability of key aspects of the study design. These findings will be used to develop a future merit within-subject
cross-over study examining the over-arching hypothesis that tailored iTBS and APT applied to a transdiagnostic
sample and subsequently matched to a Veteran, according to a biotype algorithm, will result in better functional
performance of Veteran-valued IADL. Advancing scientific capability to develop precision Veteran-tailored
transdiagnostic neurorehabilitation interventions that optimize cognitve function in daily life is aligned with VA
RR&D's mission to create knowledge and innovations advancing the rehabilitative health and care of our
Veterans.

Public health relevance
Aligned with VA RR&D's mission to create knowledge and innovations advancing the rehabilitative health and care of Veterans, this SPiRE project will scale-up the scientific basis for developing and, ultimately, delivering Veteran-tailored, interventions that improve the aspects of function identified by Veterans across neurologic diagnoses as important to their well-being. For Veterans with moderately impaired levels of cognition who are struggling with daily life, thereby requiring assistance with complex instrumental activities of daily living, this SPiRE project will explicate critical and practical barriers to developing Veteran-tailored interventions that optimize cognitve function in daily life. The SPiRE results will be used to design and conduct future merit research examining the over-arching hypothesis that restorative cognitive interventions developed according to transdiagnostic sampling and matched with a biotype algorithm, compared to a diagnosis-based algorithm, result in better functional performance of Veteran-valued IADL.